Targeting cerebrovascular Wnt/beta-catenin signaling to reverse brain endothelial damage induced by SARS-CoV-2 infection

Abstract
Many COVID-19 survivors experience long-lasting neurological post-acute sequelae of COVID-19
(NeuroPASC) including cognitive, cerebrovascular, and neurological disorders. The causes of NeuroPASC are
not understood. However, evidence suggests that blood-brain barrier damage may contribute to NeuroPASC.
Identifying mechanisms that regulate the brain endothelial cell response in NeuroPASC is therefore important.
Wnt/β-catenin signaling plays a critical role in maintaining integrity of the blood-brain barrier. This grant will
test the novel mechanism that Wnt/β-catenin dysregulation in brain endothelial cells contributes to NeuroPASC
by increasing blood-brain barrier permeability and neuroinflammation. We will determine the effect of age on
brain endothelial cell signaling and blood-brain barrier permeability for the resolution of NeuroPASC. We will
define the mechanism by which Wnt/β-catenin activation reverses blood-brain barrier leakage and memory
impairment in NeuroPASC. We will determine the extent through which transcellular blood-brain barrier
permeability contributes to NeuroPASC. These studies could identify future therapeutic strategies leveraging
Wnt/β-catenin signaling to improve chronic post-infectious neurological diseases.

Public health relevance
Narrative Age is a critical determinant of post-acute neurological sequelae of COVID-19 (neuroPASC) and vascular contributions to cognitive impairment and dementia, VCID, even after mild initial infection with vaccination. Age- related declines in blood-brain barrier stability may critically exacerbate neuroPASC in the advanced ages. Our proposed research will use mechanistic mouse models to investigate how modifications to brain endothelial cells caused by SARS-CoV-2 infection can promote neuroinflammation and cognitive impairment by destabilizing the blood-brain barrier.